CPH-NEW IV - Total Worker Health

PROJECT SUMMARY (Overall section)
The mission of the CPH-NEW Total Worker Health® (TWH) Center of Excellence is to be a national leader in
research, policy, practice, and workforce development to achieve our vision of health, safety, and well-being for
all working people. We will achieve this by: (1) conducting research on challenges, opportunities, strategies,
benefits, and costs of integrated programs for workforce health, safety, and well-being; (2) disseminating
cutting-edge TWH concepts, research findings, and program materials in multiple formats to advance
workplace practice; (3) developing policy recommendations; (4) building the capacity of professionals and
organizations to recognize the value of a TWH program and to strengthen the skills and organizational
resources needed to achieve it; and (5) educating graduate students from multiple disciplines in TWH through
their involvement in research and dissemination activities. Our proposed Center activities include two large
intervention research projects, one smaller exploratory research project, an Outreach core for research
translation and dissemination, and an Evaluation & Planning core to provide centralized administration and
support. Our research aims to integrate program models of TWH to advance workforce health, safety, and
well-being and will include: (1) a large intervention study to develop and evaluate TWH interventions designed
to improve the mental well-being of teachers, with a focus on work-life balance, burnout, and work engagement
(“Total Teacher Health”); (2) a large intervention study to develop and evaluate TWH interventions designed to
promote the health and safety of healthcare workers, with a focus on sustainability and union involvement in
implementation processes (the “SHIFT-II” study); and (3) a smaller exploratory study to develop and evaluate
professional education programs designed to integrate TWH concepts into employer crisis preparation and
planning efforts (the “TWH-ECP” study). Innovative aspects of our Center evaluation and planning methods
include the use of cross-project methodological teams, a transdisciplinary framework for sharing knowledge,
and a unique three-campus collaboration involving experts from engineering, medicine, epidemiology, public
health, nursing, psychology, education, and management. Our experience shows that a worker-centered
approach to TWH that involves workers in the design, implementation, and evaluation of interventions is an
impactful, innovative, and efficient method for improving the safety, health, and well-being of the U.S.
workforce. With this application, we propose to extend this model in new occupational settings and for new
health challenges to better engage workers in organizational decision-making that advances worker well-being.

Public health relevance
PROJECT NARRATIVE (Overall section) The CPH-NEW Total Worker Health® (TWH) Center of Excellence will conduct research and outreach activities to advance worker safety, health, and well-being using participatory worker-centered methods that engage workers in organizational decision-making to advance worker well-being. Research projects focus on the well-being, work-life balance, and organizational support of teachers; novel implementation strategies for health and safety promotion among healthcare workers; and the crisis preparedness of small- and medium- sized enterprises. The Center will also translate research to produce evidence-based workplace tools and integrated programs that can be used to promote health and well-being for all working people.